Aging and Telomere Dysfunction in the Intestinal Stem Cell Niche

Intestinal stem cell (ISC) activity declines with age, contributing to malabsorption and loss of intestinal
barrier function. ISC aging is accompanied by telomere uncapping, and the ISC defects in humans and
mice with prematurely uncapped telomeres (e.g. dyskeratosis congenita patients and mTerc KO mice)
demonstrate that telomere uncapping is a cause of ISC dysfunction. Remarkably, both aging and telomere
uncapping inhibit the canonical Wnt/β-catenin pathway, which is normally required for ISCs to support the
tissue's rapid cell turnover. Moreover, experimental restoration of Wnt pathway activity rescues ISC
defects in both settings. Although we and others have found Wnt defects in both aged and telomereopathic
intestinal epithelium and underlying stroma of mice and humans, the identities of key cellular players re
poorly understood. Recently, populations of mesenchymal cells in the lamina propria directly underlying
the epithelium have been identified as a critical source of Wnt ligands required for ISC proliferative self-
renewal. In the context of telomere dysfunction (or normal aging), ISCs exhibit a loss of self-renewal activity
and a broad downregulation of Wnt target gene expression, corresponding to the downregulation of Wnt
ligands now known to be secreted from this subepithelial mesenchyme. The goal of this proposal is to
understand the consequences of telomere dysfunction and aging on ISC niche function. We hypothesize
that both natural aging and acute telomere failure suppress stromal niche support for ISCs, contributing to
the intestinal phenotypes associated with aging and telomeropathies such as dyskeratosis congenita.
To address this hypothesis, we developed a novel mouse line that allows for direct in situ visualization and
prospective isolation of stromal niche cells (telocytes) which supply Wnt ligands to the stem cell
compartment. We will examine telocytes, along with additional niche components, in the context of
temporal aging and acute telomere failure in mTerc-/- mice lacking the telomerase RNA component
(mTerc), which leads to progressive telomere dysfunction. We will determine how aging and telomere
defects alter niche function using a combination of in situ assays, single-cell transcriptomics, and
organotypic co-culture assays in which primary stroma and intestinal organoids from either aged (vs.
young) or telomereopathic (vs. control) epithelium are isolated and co-cultured in heterochronic or
genotype admixed contexts, respectively. We will also pursue provocative preliminary observations that
wildtype bone marrow transplantation restores ISC activity in mTerc-/- mice to address the hypothesis that
marrow-derived cells can engraft into the subepithelial stroma and rescue failing epithelium. Ultimately,
this proposal will elucidate how aging and telomere dysfunction alter the ISC niche, and will begin to
evaluate novel strategies to ameliorate niche dysfunction.

Public health relevance
The internal surface of our digestive tract is covered and protected by a layer of epithelial cells, which play critical roles in digestion and pathogen defense; the integrity of this epithelial layer is maintained by a pool of active epithelial stem cells whose functions become compromised as we age. Recently, cells underlying the epithelial layer (i.e. stromal cells) that provide critical support to these epithelial stem cells have been identified, and we will investigate this stromal support is affected by chronological age, as well as by telomere dysfunction, which is an age-associated phenomenon that can disrupt intestinal stem cell function. Understanding the details of how stromal support is lost with aging may suggest new therapeutic approaches to diseases of the digestive tract.